IgE Suppressing Berberine Nanomedicine for Treatment of Peanut and Tree nut Allergies

Abstract (30 lines)
Food allergy (FA) is a substantial US public health problem, affecting over 30 million people, 1-3 causing 81%
of pediatric anaphylaxis. 4 Outside of rescue medication and avoidance, current FA treatment is limited with no
long-lasting therapeutics. Normally, IgE producing B cells and plasma cells are minor population with minimal
IgE production. Dysregulation of these cells causes excessive IgE production, a key pathological mechanism
of FA anaphylactic shock. FA is highly diverse. Peanut and tree nut allergies (PNA and TNA) are most severe,
rarely outgrown, and often co-exist.5,6 Cross reactivity among tree nut (TN) further increase the risk of reactions
complicate current practice. Despite decades of awareness about the centrality of allergen-specific IgE in food
anaphylaxis7, inhibiting IgE production by B cells/plasma remains a major challenge. Omalizumab, the anti-
IgE antibody, “traps” IgE but does not target production. Oral immunotherapy (OIT), including Palforzia® for
peanut (PN) OIT, may paradoxically increase IgE.8-13 Therefore, novel therapeutics should address broad FA
and be orally administered with sustainable suppression of food specific IgE and anaphylaxis after stopping
treatment.
We, for the first time, demonstrated that a small molecule compound berberine (BBR), isolated from
Philodendron cortex, inhibited IgE production by peripheral blood mononuclear cells (PBMC) from FA patients
at very low doses.14 real clinical barrier to use of BBR use is poor oral bioavailability.15-17 We further
developed an innovative nanoparticle-based formulation, named NIT-X. Preliminary data showed oral NIT-X
is significantly more bioavailable than parent compound with an excellent preclinical safety profile (no adverse
effects found after feeding 14x effective daily dose), and that in PN-sensitized mice 4-weeks of once-a-day oral
NIT-X at 2mg BBR within the nano particle (equivalent to a human dose of 0.3g/day, based on body surface
area18) reduced 95-100% PN-specific IgE and 100% PN anaphylaxis with effects lasting at least 28 weeks post
treatment, without affecting IgG and IgA levels. IgE+ B cells and IgE+ plasma cells were reduced nearly to
normal. An ongoing experiment showed NIT-X also worked in cashew (CSH) and walnut (WN) allergy in
addition to PN allergy in murine model. We therefore hypothesize that NIT-X, as non-food restricted
therapeutic intervention, will be effective, theoretically, for all FA by restoring normal IgE regulation. The goal
of this 2-year R21 grant is to explore NIT-X as a novel therapeutic to resolve multiple FA focusing on and
nearly all TN allergy and explore its mechanisms possibly normalize IgE regulation. Aim # 1: Determine long-
term protection against IgE-mediated anaphylaxis in PN and multi-TN allergies by NIT-X, and Aim #2:
Identify the mechanisms contributing to sustained suppression of IgE production by NIT-X. Successful
completion of this proposal would provide a strong rationale to further investigate NIT-X as a safe and effective
treatment even for those with multi-food allergies or high reaction risk. Non-food-restricted NIT-X therapy may
change the course of FA by restoration of IgE regulation, and advance clinical practice.

Public health relevance
Narrative Food Allergy is a serious and sometimes fatal condition affecting nearly 30 million people in the US for which there is currently no cure. We developed an innovative berberine nanoparticle called NIT-X that in preclinical murine studies causes rapid, selective and lasting abrogation of IgE and completely protects from anaphylaxis. Understanding how NIT-X causes sustained reduction of food specific-IgE production advances scientific knowledge of food allergy mechanisms and facilitates the development of a curative therapy.